Absolute binding free energies for virtual screening: A novel implementation of quantum mechanics/molecular mechanics (QM/MM) for FEP that allows substantial sampling and a significant quantum region

Project Summary
Computational chemistry has revolutionized drug discovery, reducing by months or even years the amount of
time it takes to discover and refine a lead candidate. Nowhere has the contribution of computational chemistry
been greater than in the realm of virtual screening (VS) to identify an initial hit to a drug target receptor. It is
now routine to screen 106-108 virtual compounds via molecular docking to identify potential binders. A small
number of these will be purchased and screened, which is a slower and more expensive process. While
docking is demonstrably useful for brute force triage, it is also generally unreliable for rank-ordering the
compounds that survive the triage. There is a substantial and unmet need for computational methods that are
better at rank ordering that can further reduce the number of compounds that survive to purchase/screening.
Interest is growing in an approach termed ABFE, in which the Absolute Binding Free Energies of diverse
ligands can be evaluated for a common protein receptor target. This approach is a natural outgrowth of relative
binding free energy (RBFE) methods, the most well-known of which is Free Energy Perturbation (FEP). In
recent years, the application of FEP for hit-to-lead optimization has exploded, thanks to increasing computer
resources and automized workflows.
With a reliable ABFE approach, further enrichment of the potential binders that come from dock-based
screening can be obtained, improving the cost/hit ratio for the expensive experimental tail of the screening
campaign.
Based on FEP, the computational formalism that would make ABFE calculations possible within the screening
paradigm has been described, and a few publications have demonstrated that it is, indeed, capable of further
enriching the compounds that survive the molecular docking screen. These calculations have still been limited
by two issues: 1) Computational throughput; 2) Limitations of the Molecular Mechanics (MM) force field that
has been exclusively used in these ABFE/FEP simulations. The limitations of computational throughput are
increasingly addressed by expansion in the availability of cloud resources, so the limitations of the MM force
field are the primary issue.
We propose an ABFE/FEP approach that replaces the limited MM representation with one based on a
combined quantum mechanics (QM) +MM approach: QM/MM—where the region of ligand binding is treated
using QM. In contrast to MM, QM describes molecular energetics much more exactly, and is broadly appliable
to all classes of molecular ligands, unlike MM, which has a large number of known limitations/deficiencies.
We will apply ABFE/FEP calculations to a variety of systems to validate the approach within the context of
virtual screening, and to demonstrate the improvements that QM/MM allows versus traditional MM approaches.

Public health relevance
Project Narrative Computational chemistry, as applied to virtual screening (VS), has fundamentally changed how drug discovery is carried out, and has appreciably shortened the timeline and improved the reliability of hit identification. However, room for improvement remains in identifying an approach that improves the ability to rank order the computational predictions from a virtual screen, and which would reduce the considerable expense and time required for the steps that follow the VS: ordering and experimental screening. We describe an approach that allows, for the first time, the absolute binding free energies of diverse ligands to be calculated using a combined quantum mechanics/molecular mechanics approach (QM/MM) integrated into the free energy perturbation (FEP) paradigm, and propose work to validate and characterize this method.